Mechanical regulation of actin binding proteins

Project Summary
PI: Daniel Fletcher, Ph.D.
NIH R01 application, PA-18-484
Project Title: Mechanical regulation of acting binding proteins
Project Period: 07/01/2019 – 06/30/2024
The actin cytoskeleton consists of spatially organized structures of filaments that are architecturally distinct and
formed from over 300 different actin-binding proteins. One of the key roles of actin networks in cells is to
generate, transmit, and resist physical forces, but whether the forces carried by actin filaments influence the
binding of actin-binding proteins is not well understood. This proposal will investigate the ability of tandem
calponin-homology domains (CH1-CH2) to bind actin filaments in a tension-dependent manner, and it will explore
the functional impact of tension-dependent binding through a set of in vitro experiments measuring the
mechanical properties of actin gels with tension-dependent crosslinkers and live cells experiments quantifying
the effect of tension-dependent signaling and cytoskeletal organization on crawling motility. The outcome of this
work will be a new understanding of how force can organize actin networks and influence the function of both
healthy and diseased cells.

Public health relevance
Project Narrative PI: Daniel Fletcher, Ph.D. NIH R01 application, PA-18-484 Project Title: Mechanical regulation of acting binding proteins Project Period: 07/01/2019 – 06/30/2024 A primary role of the actin cytoskeleton is to generates and transmit forces through cells, but it is unclear whether forces on filaments could affect the localization of the myriad actin-binding proteins in cells. Here we test the ability of the most common actin-binding domain to bind actin filaments in a tension-dependent manner and explore the effects of tension-dependent actin-binding proteins on cell migration.